Investigating how transcription factors cooperate and overcome the enhancer nucleosome barrier during embryonic patterning

Project Summary
This misregulation of gene expression underlies several human diseases, including many cancers, diabetes,
obesity, and multiple developmental disorders. Genome-wide studies and next-generation sequencing have
revealed that sequence variants in enhancers, cis-regulatory DNA sequences that control spaciotemporal gene
expression programs, contribute to the development of these diseases. These mutations often affect enhancer
activity, which must be tightly controlled since enhancers drive tissue and cell-type specific gene expression
patterns. One way that enhancer activity is controlled is through the regulation of enhancer accessibility by the
nucleosome: the structural unit of chromatin comprised of 147 bp of DNA and a histone octamer. Enhancers
are characterized by an intrinsically strong nucleosome barrier that prevents the binding of transcription factors
(TFs), the proteins that activate enhancers, until the proper context for activation is reached, at which point TFs
must overcome the nucleosome barrier and bind to the DNA. While nucleosome depletion is a key early step in
enhancer activation, we do not yet understand how the nucleosome barrier is overcome and how enhancers
are made accessible for gene activation, despite accessibility being a major regulator of enhancer activity.
Current models suggest that specialized TFs called pioneer factors can access their motifs in the presence of
nucleosomes and foment nucleosome depletion through cooperativity with additional TFs. Even still, how
pioneer and non-pioneer TFs cooperate to generate chromatin accessibility at enhancers is not yet known.
Furthermore, how pioneer factors perturb the nucleosomal landscape to facilitate chromatin accessibility and
cooperative TF binding is unclear.
This study seeks to identify how TFs overcome the nucleosome barrier at enhancers using high-resolution
experimental and computational genomics techniques to map TF binding, chromatin accessibility, and
nucleosome positioning. Aim 1 will characterize how pioneer and non-pioneer TFs cooperate for binding to the
DNA and for establishing chromatin accessibility. This aim will combine high-resolution TF binding (ChIP-
nexus) and temporally resolved chromatin accessibility (time-course ATAC-seq) information with deep learning
models (BPNet) that will reveal the sequences and sequence constraints that are important for and predictive
of TF cooperativity. Aim 2 will profile genome-wide nucleosome positional changes over developmental time at
unprecedented resolution, using a chemical mapping of nucleosome centers approach. This aim will uncover
how the nucleosome state at enhancers is altered over time to generate accessibility and how nucleosomes
are positioned with respect to the underlying regulatory DNA sequences. Taken together, these aims will
illuminate how TFs pioneer the chromatin landscape for enhancer activation, thereby deepening the field’s
understanding of the mechanisms of gene regulation and how misregulation contributes to human disease.

Public health relevance
Project Narrative Enhancers are regulatory DNA sequences that underly a wide variety of human diseases when misregulated because they determine when and where a target gene will be expressed. Because these sequences are critical for driving proper spaciotemporal target gene expression during development and cellular transitions, they are maintained in an inaccessible and inactive state until the precise context for gene activation is reached. This study aims to characterize how enhancers are made accessible and active by DNA-binding proteins during embryonic development, which will provide mechanistic insight into how cells regulate enhancer activity to control their gene expression programs.